Functional genomics of microglial phagocytosis for precision neuroimmune therapeutics

Project Summary
Alzheimer's disease (AD) is characterized by amyloid plaques, Tau neurofibrillary tangles, and synapse loss.
While amyloid targeting immunotherapies have shown some modest success, there is a critical unmet clinical
need for more effective therapeutics as the prevalence of AD increases globally. Microglia, the brain resident
macrophage, significantly influence all of the pathological hallmarks of the disease through phagocytosis, and
many AD genetic risk factors are exclusively expressed by these immune cells. This project aims to develop
the first in vivo CRISPR screening platform to identify genetic regulators of microglial phagocytosis in AD,
focusing on (1) amyloid phagocytosis in combination with amyloid-targeting antibodies, (2) Tau phagocytosis
via suppressor screens in microglia harboring rare genetic variants that prevent Tau aggregate spread, and (3)
the discovery of regulators of microglial synapse phagocytosis to preserve cognitive function in AD mouse
models. By leveraging recently developed methods for hematopoietic stem cell gene editing, barcoding, and
microglial transplantation in AD models, this research will uncover novel therapeutic targets to enhance
microglial function, potentially leading to more effective treatments. The insights gained will have broad
implications for understanding the biology of tissue-resident macrophages and for diseases involving
macrophage phagocytosis, including cancer and atherosclerosis.

Public health relevance
Project Narrative: This project aims to develop the first in vivo CRISPR KO genetic screening platform to identify genetic regulators of phagocytosis in microglia, the brain resident macrophage, in the context of Alzheimer's disease. By leveraging advanced hematopoietic stem cell gene editing, barcoding, and transplantation into disease models, this research will uncover novel therapeutic targets to enhance microglial function and mitigate cognitive decline in AD. The findings and methods developed here will have broad implications for understanding the basic biology of tissue resident macrophages and diseases involving tissue-resident macrophage phagocytosis, such as cancer and atherosclerosis.